ANIMAL CORE

PROJECT SUMMARY (See instructions): Core C will provide all animals required in the 4 Projects. Lovelace Biomedical and Environmental Research Institute (LBERI) has outstanding animal facilities and unique experience in veterinary care. This is a critical premise for studies of physiological myocardial aging in small and large animal models. Additionally, this Core will be responsible for delivering 14C-labeled thymidine to wild-type and transgenic mice, and dogs. Importantly, animals will be maintained at LBERI until shipment to the investigators' laboratories.

Public health relevance
This Core will provide animals required in Projects 1-4.